A systematic study of the environmental etiology of autism spectrum disorder using high-throughput behavioral screening

ABSTRACT
Both genetic and environmental factors influence the risk of developing autism spectrum disorder. Environmental
contributions in particular, are estimated to account for ~40% of autism risk, yet we know very little about the
identities of these environmental risk factors for autism. To bridge this gap in knowledge through an experimental
approach, I developed a zebrafish-based high-throughput behavioral assay of sociality during my postdoctoral
training. Social deficit is one of the two core symptoms of autism and a hallmark of this disease, so I hypothesized
that environmental inhibitors of sociality are also likely risk factors for autism. Using this assay, I conducted a
large-scale screening of 1120 compounds and discovered topoisomerase II (Top2) inhibitors as a class of
environmental chemicals that inhibit the development of sociality and likely contribute to autism risk. The main
objective of this proposal is to characterize the role of Top2 in the development of social behavior. During the
K99 award period, I demonstrated that between the two isoforms of Top2, Top2a but not Top2b is required for
the normal development of sociality. In addition, I discovered that Top2a likely functions by interacting with the
polycomb repressive complex 2 (PRC2) and regulating H3K27 trimethylation (H3K27me3) in specific genomic
loci. I also gained skills and knowledge in mouse genetics, mouse behavioral science, genomics, and
bioinformatics. With the new training and mechanistic insights acquired in the K99 phase, I will extend the scope
of my research in the R00 phase to: 1) establish and characterize a genetic mouse model of Top2a depletion
through conditional knockout; 2) examine genome-wide changes in H3K27me3 distribution following Top2a
inhibition; and 3) systematically discover environmental factors that affect the development of social behavior by
screening the ToxCast library. Together, the proposed research will greatly facilitate environmental risk factor
discovery for autism and may reveal novel therapeutic targets to prevent or treat autism. The support that the
R00 award provides will help me achieve my long-term goal of establishing a successful independent research
program to investigate environmental impacts on mental illnesses.

Public health relevance
PROJECT NARRATIVE Environmental risk factors account for ~40% of autism risk, yet we know very little about the identities of these factors. I developed a zebrafish-based high-throughput behavioral assay to systematically discover environmental chemicals that induce social deficits, a hallmark of autism spectrum disorder, and revealed topoisomerase II alpha (Top2a) as a key regulator of social development. This proposal will further investigate the mechanism underlying this pathway, and continue to discover environmental risk factors for autism using the screening system I developed.